Detecting Growth of Intracranial Aneurysms Using Non-Invasive Photon Counting CT in a Murine Model.

Abstract: Unruptured intracranial aneurysms (UIAs), particularly those between 3-7 mm in diameter, present
significant clinical challenges due to their potential for growth and rupture. Early and accurate detection is
critical for effective management, as current invasive interventions carry substantial risks and costs. Emerging
evidence suggests that Aspirin (ASA) may be a viable, cost-effective alternative for mitigating the growth and
rupture of UIAs, with its effectiveness varying by sex due to differences in enzymatic activity related to ASA
metabolism. This project aims to leverage recent advances in Photon Counting CT (PCCT) imaging to
enhance our understanding and treatment of UIAs in mouse models, addressing the critical need for
noninvasive imaging techniques. In Aim 1, we will establish optimized PCCT protocols for mouse brain imaging
using both blood pool and conventional contrast agents and focusing on achieving high-resolution, detailed
visualization of cerebral arteries and aneurysm morphology. By optimizing parameters such as X-ray dose,
detector settings, and image reconstruction algorithms, we aim to provide the best possible image quality for
this challenging task. Aim 2 involves validating PCCT imaging (both in vivo and ex vivo) against histological
analysis in the same subjects to ensure accurate multimodal characterization of UIAs. Direct comparison of
imaging findings with actual tissue morphology will confirm the reliability of PCCT imaging and establish it as a
non-invasive alternative for monitoring UIA growth. In Aim 3, we will conduct longitudinal PCCT studies to
assess the efficacy of ASA in slowing UIA growth and maintaining wall integrity in male and female animal
models. This aim will provide insights into sex-specific vulnerabilities and the differential effects of ASA
treatment on UIAs. The expected outcomes include establishing PCCT as a reliable, non-invasive method for
early detection, accurate characterization, and effective monitoring of UIAs. Additionally, this research will
elucidate the sex-specific therapeutic effects of ASA, paving the way for personalized treatment strategies and
reducing reliance on invasive procedures. By integrating cutting-edge imaging technology with advanced
therapeutic approaches, this project has the potential to transform the management of UIAs and significantly
improve patient outcomes. Furthermore, the innovative application of PCCT imaging in preclinical models will
set new standards for non-invasive vascular imaging, offering unprecedented resolution and contrast for
detailed cerebrovascular studies.

Public health relevance
Project Narrative: This project aims to advance the non-invasive detection and treatment of unruptured intracranial aneurysms (UIAs) by developing and optimizing high-resolution Photon Counting CT (PCCT) imaging protocols tailored for small animal models. It seeks to validate the accuracy of PCCT imaging against traditional histological methods and assess the efficacy of Aspirin (ASA) in mitigating UIA growth, with a focus on sex-specific responses. Through these efforts, the project aspires to provide detailed insights into UIA development and treatment, ultimately paving the way for personalized therapeutic strategies.